Identification of mosquito brain neurons that drive blood-feeding behavior

PROJECT SUMMARY
Mosquitoes transmit numerous pathogens to humans by virtue of their ability to locate and bite vertebrates.
Current strategies to prevent these diseases face various limitations and new approaches are needed. One
possibility would be to inhibit the neurons in the mosquito brain that direct the behavior of attraction to humans
and feeding on blood, but such neurons have not been identified because the tools and knowledge to do so do
not exist. This proposal describes my plan to use genetic and sequencing-based approaches to identify the
neurons that are required for blood-feeding behavior. I will take advantage of the fact that mosquitoes require
multiple human-derived cues, particularly heat and CO2, to engorge on blood. Using gene expression changes
in single cells, I will identify neurons that show altered responses specifically in the presence of both stimuli. To
enable the genetic targeting of specific cell types of interest, we will create an atlas of enhancer elements that
are specific to each cell type in the mosquito brain, using paired single cell RNA and ATAC-seq data. Finally,
we will target key neurons for blood feeding using an enhancer driver constructs and combine them with
genetic effectors to test whether the neurons are necessary and sufficient for blood feeding behavior. This
proposal combines my expertise in computational genomics, transgenic mosquitoes, and behavior to achieve
the goal of identifying neurons at a key node in the neural circuits for blood feeding. The identification of these
neurons that drive blood feeding would be useful for understanding how they are activated and thus allow the
design of more attractive mosquito traps. These neurons, if inactivated, would prevent mosquitoes from biting
humans so they also could serve as a potential target to disrupt the spread of mosquito borne illness.

Public health relevance
NARRATIVE Mosquitoes spread pathogens to humans through their behavior of blood feeding and identifying and understanding the neurons that control this behavior would enable new strategies to prevent it. Here, I describe an approach using genomics, transgenic mosquitoes, and behavior studies to identify the neurons that are required for mosquitoes to seek out and bite humans. The identification and genetic targeting of these neurons will create a way to understand what causes the attraction of mosquitoes and open new avenues for its prevention.